Brain Connectivity Changes with Spinal Cord Stimulation Treatment of Chronic Pain: A Resting State NIRS/EEG Study

Chronic pain is a complex neurological disease that adversely impacts function and quality of life.
Brain structure and function are altered when an individual is in the chronic pain state.
Furthermore, chronic pain is associated with disruptions in functional brain connectivity. Spinal
cord stimulation (SCS) is a clinically available non-pharmacological therapy that is used in the
management of chronic pain. Although SCS is effective for many, there are individuals who do
not benefit. Therefore, in order to better understand brain mechanisms that underlie SCS
treatment of chronic pain and to develop brain biomarkers of SCS efficacy, we propose to evaluate
functional brain changes in response to SCS. Finding a brain signature of pain relief in response
to SCS would improve understanding of how SCS alleviates chronic pain and may help to identify
those most likely to respond. The main objective of this study is to assess changes in brain
connectivity in response to SCS in individuals with chronic neuropathic pain. We will study two
cohorts: Cohort 1 – naive to SCS patients who are undergoing SCS trial period; Cohort 1 – long-
term SCS users (≥6 months post implantation). We aim to identify neurophysiological brain
signatures of pain relief in these two populations using resting state Near Infrared Spectroscopy
and Electroencephalography (rs-fNIRS/EEG).
Study Design: We will enroll veterans with refractory chronic neuropathic pain who are currently
receiving clinical care within the medical center. Cohort 1: Individuals with chronic neuropathic
pain who are naïve to SCS and were selected for SCS trial period as part of their clinical care will
participate in two study visits: before the beginning of the SCS trial and the end of the trial period.
Data collection will be consistent across all data collection timepoints (T1 – T3) and include rs-
fNIRS/EEG and clinical pain measures. Cohort 2: Participants with effective implanted SCS ≥ 6
months will participate in three study visits conducted 24-48 hours apart. Data will be collected
during SCS use and following an SCS washout period. Data collection will be consistent across
all data collection timepoints(T1-T4) and include rs-fNIRS/EEG and clinical pain measures. Both
cohorts will receive paresthesia based SCS.
AIM 1 is to characterize neurophysiological (rs-fNIRS/EEG) brain signature of pain relief during
the SCS trial period for patients with chronic neuropathic pain who are naïve to SCS. AIM 2 is to
characterize neurophysiological (rs-fNIRS/EEG) brain signature of pain relief in patients with
chronic neuropathic pain who have utilized SCS for ≥6 months. Outcome Measures to address
both aims include rs-functional connectivity (rs-fNIRS/EEG); and a composite clinical pain
assessment that will include Numeric Pain Rating Scale (NPRS), Patient Reported Outcomes
Measurement Information System-29 profile v2.1(PROMIS-29); EQ-5D-5L; Patient Global
Impression of Change (PGIC); painDetect; and activity monitoring.
Significance: Studying changes in brain connectivity in response to SCS will provide insight into
the treatment mechanism of SCS. Use of neuroimaging methods such as rs-fNIRS/EEG that can
be easily applied in the clinical setting to further refine patient selection for SCS may improve
outcome in SCS therapy. This grant will provide preliminary data for future studies aimed at
developing biomarkers of pain-relief with SCS treatment.

Public health relevance
Chronic pain is a complex neurological disease associated with maladaptive structural and functional brain changes. It is prevalent in Veterans, adversely impacts their function and quality of life and is often treatment resistant. Spinal cord stimulation [SCS] is a minimally invasive, non-pharmacological therapy for treatment of chronic pain. However, little is known about how SCS impacts brain function. Our purpose is to evaluate neurophysiological response to SCS in individuals with chronic neuropathic pain. We will study two cohorts: Cohort 1 - naive SCS users (undergoing an SCS trial period) and Cohort 2 – long-term SCS users (≥6 months post implantation). We aim to identify the neurophysiological brain signature of pain relief using resting state Near Infrared Spectroscopy and Electroencephalography (rsNIRS/EEG). Results from this study will provide valuable information regarding the effects of SCS on the cortical connectivity networks during both trial SCS period and long-term SCS use in chronic neuropathic pain.